RESEARCH TRACK RESIDENCY TRAINING PROGRAM

This application seeks support for a unique, five year Research Track Program embedded in an existing, highly successful residency program at the Department of Psychiatry, University of Maryland School of Medicine. The goals of the program are to recruit talented medical graduates into the Residency Research Track Program, and provide extensive research training, opportunities to conduct hands on research with long-term mentorship during the course of their extended residency training. This will provide tools to talented medical graduates early in their training to become independent and productive investigators in mental illness. The training has three components: (i) formal courses in biostatistics, research design, and neuroscience; (ii) participation in experiments in the mentor's laboratory; and (iii) initiation of an independent project with the mentor's guidance, and support from a competitive Pilot Projects Funds. The setting for this proposed training is a mature, academic Psychiatric Department which has an active federally funded research portfolio, hosts two NIMH supported centers, the Intervention Research Center and the Center for Research on Services for Severe Mental Illness, and has a vibrant basic neuroscience presence. The Department has an excellent track record of training productive investigators in schizophrenia and other mental illnesses.